Core B: Bioinformatics and Functional Genomics Core

PROJECT SUMMARY/ABSTRACT – BIOINFORMATICS AND FUNCTIONAL GENOMICS CORE
The Bioinformatics and Functional Genomics (BFG) Core forms a foundation for the P01 application by providing
critical resources including functional genomics and biostatistical capacity to all three projects, to support the
overarching goals of identifying the molecular drivers of prostate cancer (PC) and biomarker development. The
performance of translational research mandates that investigators have ready access to advanced experimental
approaches, clinical genomics analysis, and biostatistical support and analytical capacity. To accomplish the
objectives of the Core, to support the P01 projects, we designed three Specific Aims:
Specific Aim 1: To provide support and expertise for clinical genomics analysis, integrating rapid
autopsy data with mCRPC tumor and liquid biopsy data to enable efficient data sharing and
management. The BFG core will integrate clinical genomics data from metastatic prostate tumor biopsies
including but not limited to transcriptomic, methylation, and chromatin conformation assays. The core will perform
analysis on these assays to assist project teams in target analysis and development of mechanistic hypotheses
for individual projects.
Specific Aim 2: To provide support and expertise for bioinformatics studies across the P01 projects,
including the execution and analysis of functional genomic screen experiments employed in all P01
projects. The BFG core will execute and perform bioinformatic analysis on high-throughput perturb-seq CRISPR
screens that will identify transcriptional modulators of ARPC, DNPC, and NEPC subtypes of prostate cancer.
Specific Aim 3: To provide support and expertise in biostatistical design, analysis, and dissemination of
results from P01 biomarker studies. The core will be a resource for all three projects in project aims that
involve the design and development of prognostic and predictive biomarkers derived from liquid biopsy studies
performed on clinical trial samples. The core will also serve as a consultant for the design and interpretation of
in vivo animal studies.
The Bioinformatics and Functional Genomics Core is highly integrated with all three Projects and all Projects will
rely significantly on the Core resources and expertise.

Public health relevance
PROJECT NARRATIVE – BIOINFORMATICS AND FUNCTIONAL GENOMICS CORE The Bioinformatics and Functional Genomics (BFG) Core will provide critical resources to all three P01 projects to support the overall goals of identifying molecular drivers of prostate cancer lineage plasticity and biomarker development. These resources include bioinformatic analysis and integration of clinical genomic data, executing and interpreting functional genomics studies using CRISPR screening technologies, and oversight of the design, implementation, and interpretation of biomarker studies using clinical trial samples.